New oral antibiotics focused on treating MDR Gram-negative infections

Project Summary
Cūrza is developing a new class of broad-spectrum antibiotics, focused on multidrug-resistant (MDR) Gram-
negative pathogens. The CZ-02 program is directed towards inhibitors that bind to a unique site on the bacterial
ribosome that is not targeted by approved antibiotics and have not encountered cross-resistance to other
antibiotics used clinically. Inspired by a natural product, analogs have been developed that selectively inhibit
bacterial protein synthesis, with little effect on mammalian protein synthesis, through a binding interaction with
the ribosome at a clinically un-drugged site. The natural product that inspired CZ-02s has multiple metabolic
liabilities and lacks activity against Gram-negative pathogens. However, after re-engineering the natural
product’s minimum pharmacophore responsible for activity into new chemical matter, the resulting compounds
are metabolically stable, exhibit excellent selectivity and potency for bacterial protein synthesis while sparing
mammalian ribosomes and are efficacious against MDR pathogens in vitro and in vivo; all while displaying a lack
of cytotoxicity toward mammalian cells and avoiding effects on mitochondrial function. The proposed SBIR
project will ultimately deliver a new orally administered antibiotic candidate that is potent with broad-spectrum
activity and efficacy, focusing on Gram-negative pathogens.
This Direct Phase II project will advance the CZ-02 program by the following aims. Aim 1 will pursue parallel
paths for oral bioavailability of CZ-02s. One will adopt formulation technologies that have proven successful for
other therapeutics to maximizing oral bioavailability for either of 2 late preclinical stage CZ-02s.The second will
pursue a medicinal chemistry approach for optimizing physicochemical properties of CZ-02s to impart inherent
oral bioavailability to the scaffold. Rigorous microbiological and biochemical evaluation along with profiling of
absorption, distribution, metabolism, excretion and toxicity (ADME-Tox) will guide optimization efforts. Aim 2 will
use in vivo pharmacokinetic (PK) evaluation to guide optimization along with maximum tolerated dose (MTD)
determination to guide in vivo efficacy initially in mouse septicemia models to select lead compounds for
evaluation in complicated urinary tract infection (cUTI) models of K. pneumoniae and E. coli (the pathogens most
responsible for cUTIs) for down-selection to a single lead candidate. Aim 3 will provide scale-up chemistry to
support in vivo studies. Aim 4 has sophisticated PK/pharmacodynamic (PD) profiling to establish the PD driver
of efficacy and definition of the optimal dosing regimen in acute pyelonephritis (AP) models.
At the culmination of the project, a lead compound will be ready for two species non-GLP toxicology and
subsequent IND-enabling studies to ultimately deliver a new antibiotic from a novel class targeting Gram-
negative pathogens.

Public health relevance
Project Narrative This project will lead to the development of the first new class of oral antibiotics in over 40 years to treat infections caused by Gram-negative bacteria, especially life-threatening multidrug-resistant pathogens. The antibiotics to be developed have a novel mechanism of action which should limit the occurrence of resistance and are not expected to encounter cross-resistance to other antibiotic classes. These antibiotics represent an exciting option to address the growing concern of antimicrobial resistance.